OPTIMIZATION OF IMAGING MODE USED TO FOLLOWING CENTROSOMES IN FUSED CELLS

It is unknown if the formation of mitotic spindles in vertebrate somatic cells require both chromosomes and centrosomes or whether a spindle-like structure can be formed by the two replicated and separated centrosomes alone. We have found that fused cells often have redundant centrosomes that are quite far from the forming spindle when the cell undergoes mitosis. These centrosomes form a radial array of microtubules, but these microtubules can not physically interact with chromosomes. We used various BMIRR imaging modes to detect and follow the "free" centrsomes in living cells. We have determined that phase contrast microscopy is the best method for this work and we are now continuing this study in collaboration with Ms. Jeannette Hays (a student at Russell Sage College).